Single-cell transcriptional atlas of Giardia encystation

Project Summary
Differentiation into dormant encapsulated cell types, known as encystation, is one of the most common modes
of eukaryotic differentiation. Importantly, these changes cause the parasites to release from the host intestine,
thus this process could be targeted to clear infections and/or block transmission. Despite its importance, very
little is understood about the regulation of Giardia encystation. Here we propose to use single-cell RNA
sequencing (scRNAseq) to build an atlas of gene expression during the cell cycle (Aim1) and during
differentiation into cysts (Aim2). cAMP signaling is necessary and sufficient to initiate the encystation but not
induce the formation of fully formed cysts. Hence, additional signals are required for cyst formation, and we aim
to address this important question using scRNAseq. Together these studies will deepen our understanding of
the encystation program and reveal unappreciated pathways that work to control the balance between
persistence of infection versus transmission of this major parasite and model for the regulation of encystation.

Public health relevance
Public Health Relevance Statement Giardia is the causative agent of giardiasis, a prevalent gastrointestinal illness that results in diarrhea and malabsorption in more than 200 million people each year. This proposal investigates encystation, the act of differentiating into environmentally resistant cysts that are the means of dissemination for this parasite. Encystation involves parasite detachment from the host intestine; therefore, misregulation could be exploited to block transmission or to clear infection.